The role of stroke risk factors in the prevalence of stroke symptoms among Hispanic/Latinx Adults

PROJECT SUMMARY/ABSTRACT
Hispanic/Latinx adults exhibit a significantly greater incidence of total stroke, younger age at stroke mortality,
and worse neurologic, cognitive, and functional outcomes post-stroke than Whites. Identifying Hispanic/Latinx
adults at high risk of stroke is critical to eliminating racial/ethnic inequities in stroke and long-term stroke
outcomes.
The Questionnaire for Verifying Stroke-Free Status is as a novel and validated screening tool used to identify
individuals at a high risk of incident stroke through the self-report of stroke symptoms (sudden onset of
unilateral weakness, unilateral numbness, loss of vision, loss of half-vision, inability to understand, and inability
to communicate). Endorsement of at least one stroke symptom is predictive of total stroke incidence
irrespective of other stroke risk factors, based on data from clinical and epidemiologic studies. However,
current research has focused exclusively on non-Hispanic Black and White adults. Due to variability in the
prevalence of stroke risk factors and social determinants of health among Hispanic/Latinx adults compared to
other racial/ethnic groups, the relationship between stroke risk factors and stroke symptoms among and
between Hispanic/Latinx adults is uncertain.
This innovative project will address the critical gaps in our knowledge of the relationship between
stroke risk factors and stroke symptoms among Hispanic/Latinx adults by (1) assessing the association
between hypertension, diabetes (severity and clinical control) and stroke symptoms and variability across
heritage group and (2) determining the clinical, socio-economic and socio-cultural factors explaining
differences in stroke symptoms across Hispanic/Latinx heritage groups. These aims will be accomplished by
utilizing previously collected data on stroke symptoms among participants of Hispanic Community Health
Study/Study of Latinos (HCHS/SOL) as an extension of the Principal Investigator's National Heart, Lung and
Blood Institute (NHLBI) funded K01 award (HL124391). The HCHS/SOL is a prospective NIH-funded cohort of
over 16,000 Hispanic/Latinx adults of heterogenous heritage from four geographic regions. This application
will also contribute to the NHLBI's strategic objectives to address disparities in health by filling crucial
gaps in our understanding of stroke risk among and between Hispanic/Latinx adults and by promoting
biomedical workforce diversity through the support of the applicant, a Latina investigator, transitioning toward
independence. These data will be used to inform future R01 applications to implement culturally tailored
messaging and screening interventions to identify Hispanic/Latinx adults at high risk of stroke.

Public health relevance
PROJECT NARRATIVE Hispanic/Latinx adults have a significantly greater incidence of total stroke, younger age at stroke mortality, and worse neurologic, cognitive, and functional outcomes post-stroke than Whites. Identifying Hispanic/Latinx adults at high risk of stroke is critical to eliminating racial/ethnic inequities in stroke. This project will address important gaps in our knowledge by assessing the association between hypertension and diabetes with stroke symptoms, examining whether those associations vary across Hispanic/Latinx heritage group, and by determining which clinical and socio-economic/socio-cultural factors explain differences in stroke symptoms between Hispanic/Latinx heritage groups.